Optimizing Psychotherapy for Older Veterans with Chronic Pain

The overarching goal of the proposed research is to learn how to optimize psychotherapy for those Veterans
most in need and most likely to benefit from psychotherapy, older Veterans with chronic musculoskeletal pain.
Chronic pain is a critical healthcare challenge, as the condition affects 50% of all Veterans and affects older
Veterans most commonly, severely, and persistently. For years, chronic pain treatment has been notoriously
difficult at VA and elsewhere, especially in light of the recent “opioid crisis,” in which opioid analgesics,
previously a mainstay of chronic pain treatment, have come under increased scrutiny. In response, CDC,
VA/DoD, and some experts have called for enhancing and expanding psychosocial treatment options for
chronic pain, such as psychotherapy, which are low risk for older Veterans who frequently have multiple
medical comorbidities and are taking multiple medications.
Yet standard VA psychotherapy approaches, such as Cognitive Behavior Therapy (CBT), have shown modest
benefits for Veterans on pain and other related patient-centered outcomes (PCO), such as mood, anxiety, and
sleep. In contrast, a novel psychotherapy approach, Emotional Awareness and Expression Therapy (EAET),
has shown medium to large benefits for some chronic pain patients. Whereas CBT improves pain and
negative emotion by teaching patients cognitive and behavioral coping skills, affecting brain regions
that enhance “cognitive control” of pain, EAET operates primarily through emotion regulation, which is
thought to influence brain regions and circuits that modulate both physical pain and emotion—a
mechanism absent from existing approaches. The literature and our pilot data indicate that patients
who express a significant amount of emotional distress at baseline, such as high anxiety and
depressive symptoms, may be particularly likely to benefit from EAET’s emotion regulation approach,
whereas patients who express less emotional distress may derive more benefit from an approach like
CBT, which does not require ready access to emotions.
The proposed randomized clinical trial tests the hypothesis that EAET is superior to CBT on reduction in mean
pain severity and other PCO (derived from IMMPACT recommendations). To examine which patients are most
likely to benefit, this research also tests whether greater baseline emotional distress (using measures of
anxiety and depression) predicts stronger benefits from EAET and whether lower baseline emotional
distress predicts stronger benefits from CBT. Finally, this research explores whether the benefits of
EAET are mediated by improved emotion regulation (using measures of ambivalence over emotional
expression and emotional approach coping), the benefits of CBT are mediated by improved cognitive
and behavioral coping (using measures of pain catastrophizing and adaptive coping), and whether the
benefits of both are mediated by a stronger working alliance. We plan to enroll 160 multi-ethnic/multi-
racial older Veterans (age 60-95 years) with chronic musculoskeletal pain at the West Los Angeles VA Medical
Center, an ideal environment as the largest VA Medical Center on the West Coast.
This research can introduce an additional, potentially more effective format of psychotherapy at VA so
that more Veterans with chronic pain can respond. In addition, this research can lead to better
treatment targeting and enhance our understanding of how psychotherapy treatments work. Finally,
this research can facilitate the development of critical skills for the PI in psychotherapy research and
pain management and enhance his ability to effect positive change for older Veterans.

Public health relevance
The goal of the proposed research is to learn how to optimize psychotherapy for older Veterans with chronic pain. Chronic pain affects 50% of all Veterans and up to 80% of older Veterans and is notoriously hard to treat. VA recommends psychotherapy as an important treatment for chronic pain, but standard psychotherapy, including Cognitive Behavior Therapy (CBT), produces only modest benefits. In published data and pilot work, a new psychotherapy approach, Emotional Awareness and Expression Therapy (EAET), has shown medium to large benefits for some Veterans. The proposed research evaluates whether EAET is more effective overall than CBT for older Veterans with chronic pain, examines whether psychiatric symptoms like depression and anxiety can predict which Veterans are most likely to respond, and explores how each treatment works. If successful, this research could lead to more Veterans with chronic pain responding to psychotherapy and better targeting of each psychotherapy to Veterans most likely to benefit.